Using Network Analysis to Assess School Mental Health Organizational Structure

DESCRIPTION (provided by applicant): Despite our increasing attention to the provision of school based mental health services, barriers remain to our understanding of how mental health services may be effectively implemented, integrated and sustained in school settings. Part of this difficulty rests with the tremendous burden facing educators in high stakes school environments where performance accountability is at an all-time high. Equally contributing to this difficulty are barriers in implementation and the translation of programs from 'bench-side to bedside' that include not only issues of leadership and readiness for change, but also issues of professional competencies and training, and organizational and structural barriers to operation. In school settings organizational barriers are particularly salient, as mental health professionals and education professionals must address not only their own organizational barriers, but those of the other professional group as well. Therefore a necessary step in advancing the science of school based mental health involves a more thorough understanding how the organization of services in schools contributes to mental health service quality. The purpose of the proposed pilot study is to utilize a service systems research methodology, social network analysis, to assess and understand the nature of communication and role structures among school based mental health professionals and teachers. Because school based mental health services are inclusive of prevention oriented, targeted, intensive services, and crisis interventions, the network analysis includes all levels of service intensity. Based on the limited capacity of the funding mechanism and the pilot nature of the research, the study will be limited to middle school populations, which will allow a sufficient set of schools from which to choose appropriate samples, while maximizing the use of a population for whom mental health services are particularly relevant. The social network analysis will be used to identify the structure of communications and roles among all professional groups within schools. Differences within communication and role structures across service intensity will be compared, and the contribution these structures make to the quality of mental health integration will be assessed. This pilot study will be coordinated by an advisory team composed of the research team, school district student service leaders, and nationally recognized experts in school based mental health services and implementation science. Contingent on our findings, the research will be expanded through R01 funding mechanisms to more thoroughly assess how communication and role structures contribute to individualized mental health outcomes for children, how organizational structures contribute to efficiency and sustainability of school based mental health services, and through R34 funding, how schools may better encourage and facilitate the communication and role structures that are most conducive to effective services through training and professional development practices.

Public health relevance
PUBLIC HEALTH RELEVANCE: According to the Surgeon General, mental illness remains one of the most significant threats to a healthy society. Among children, most of those who need mental health services will receive them through the schools, yet significant difficulties arise in the successful implementation of school based mental health services. This pilot study assess the nature of organizational role and communications structures among teachers and mental health professionals, and the contribution these organizational factors make to the quality of mental health services with the results of this effort having immediate implications for improving the health and welfare of children and adolescents. __SpecificAimsTextDelimiter__ Specific Aims: For children and youth with behavioral and mental health concerns, schools have been described as the de facto provider of mental health services for children with behavioral and mental health problems, and school systems provide the majority of services to children who receive them1,2. In spite of the country's dependence on the school system, the field has little scientific knowledge about how schools can best organize school-based mental health (SBMH) services to ensure the consistent delivery of high quality care. Through the lens of translational science, this proposal will examine organizational drivers that are critical to ensuring that school systems operate in ways to enable mental health program success.5,6 Among the most promising organizational drivers are the formal and informal communication networks among school personnel that activate when a child displays mental health problems. These communication networks provide a detailed picture of the complex roles that school personnel play (or could potentially play) when a child demonstrates mental health problems. A better understanding of these networks and their relationship to outcomes can provide a solid foundation for developing an intervention to improve outcomes by strengthening critical communication networks to ensure the effective mental health service implementation in school systems. Building upon the strong relationship between the PI and the Hillsborough County School District, a large and culturally diverse district with an active agenda for improving the integration of school mental health services, this proposal seeks to: Specific Aim 1: To describe the communication network that activates in each school when a child displays a mental health problem. The research team proposes to develop eight vignettes to characterize the formal and informal communication networks involving child mental health in each school. Each vignette will ask the respondent to identify individuals inside the school from whom they seek advice/recommendations when a child displays a mental health problem. This data will be used to describe the density, centrality and reciprocity of formal and informal communication networks involving child mental health in each school. Specific Aim 2: To examine how these communication networks differs across service intensity. The research team expects that characteristics of both formal and informal communication networks will differ by problem severity. Thus, we propose to compare network characteristics across universal, targeted, intensive, and crisis intervention services. We expect that formal communication networks for crisis intensive and intervention services will have greater density and centrality than networks for universal and targeted services. Specific Aim 3: To examine the relationship between communication networks and mental health system outcomes. The research team will assess the relationship between network characteristics and integration of the mental health service systems in the school. Key components of integration include access, recognition/referral and collaboration/coordination. We expect that the density, centrality, and reciprocity in formal communication networks will be associated with each of these key components. We will also explore these relationships in informal communication networks. We propose that this effort is significant because despite evidence that increasing the integration of SBMH services improves academic outcomes, the field knows little about how organizational factors contribute to effective SBMH services in schools. Increasing knowledge in this area requires an investigation of how organizational characteristics like communication networks impact SBMH service integration.6 National groups recognize the significance of the proposal's translational perspective in improving children's mental health including the President's New Freedom Commission on Mental Health3 and the Surgeon General's Report,4 the National Council and Institute of Medicine Report.6 The proposed work is also innovative. Despite rigorous evidence documenting the importance of communication networks in the provision of high quality educational instruction,51 the value of communication networks in the provision of high quality SBMH services has never been studied. 25, 46, 47 By adapting a widely regarded conceptual SBMH framework to include social networks, the research team can identify key organizational characteristics in schools that can be potentially modified by novel interventions to improve SBMH outcomes.